The behavioral and neurocognitive effects of bilingual experience on cognitive control and language processing: Implications for aging in two languages

Project Summary/Abstract
Healthy aging negatively affects performance in specific aspects of cognitive and language function that are
crucial for everyday life decisions and actions. Crucial to understanding and promoting successful aging is
determining the impact of lifestyle factors such as bilingualism for particular neurocognitive functions. Bilinguals
vary in their experience with respect to how, when, and where they use their languages, yet little research to
date has examined the impact of diversity of bilingual experiences on language and cognitive function and brain
organization. Here, we capitalize upon cutting edge cognitive neuroscience methods to investigate how
differences in the social diversity of language use may modulate the impact of bilingualism on language and
cognitive functioning over the adult lifespan. In doing so, this research will contribute to our knowledge about
how the brain orchestrates its response to the demands of people’s life experiences and the extent to which
neurobiological systems involved in language and cognitive control are plastic.
This project has three specific aims. The first is to establish a link between the lifespan trajectory of language
experience and how this may differentially modulate the impact of bilingualism on cognitive functioning. To
examine variability in bilingual language experience, and cognitive control, French-English bilingual speakers
ranging from 18-75 years of age will complete a battery of linguistic and cognitive measures. Participants will
also be administered a new measure of language entropy, which characterizes diversity of language use across
social spheres. Montreal provides a valuable test bed for testing the impact of these experiential factors while
holding relatively constant other demographic factors that are known to influence language and cognitive
functions (e.g., SES, education). Second, this proposal aims to determine the extent to which lifelong bilingualism
provides compensation against age-related declines in language performance. We test to what extent cognitive
control is engaged during language processing and how preserved cognitive control abilities in aging affects
language performance. Finally, neuroimaging research shows that bilingualism is associated with structural
differences in the brain; however, the extent to which bilinguals’ contexts of language use modulates these
differences remains unclear. Thus, we aim to spell out the neural bases of adaptive changes related to bilingual
language experience throughout the adult lifespan. Identifying these changes will not only have implications for
further understanding healthy neuroplasticity and how the brain adapts to different kinds of experience, but will
also lay the groundwork for understanding atypical brain development and neurological disorders (e.g., learning
disabilities, stroke) in our increasingly bilingual population. Altogether, the cognitive and language science
community at McGill University provides an environment that is exceptionally suited as a rich training ground
in bilingualism and cognitive aging and in using neuroscience methods; this training will provide the applicant
with interdisciplinary skills and knowledge as she moves towards an independent research career.

Public health relevance
Project Narrative Bilinguals vary in their experience with respect to how, when, and where they use their languages, yet little research to date has examined the impact of diverse bilingual experiences on cognitive performance, language abilities, and brain organization. In the planned experiments, we examine whether bilingual experience over the adult lifespan impacts individuals in a way that differentially buffers against age-related declines in cognitive function and language performance. Determining the consequences of language experience holds important implications for better understanding cognitive aging in our increasingly bilingual population, and also the constraints and plasticity that define the relation between language and cognition more generally.